Viral Replication Pathways During Oral Tumorigenesis and Response to Therapy

In Human Papillomavirus (HPV) cancers, viral replication pathways involving the HPV oncogenes E6 and E7
are co-opted to promote cancer cell proliferation. However, the altered cellular pathways downstream of these
HPV oncogenes remain unclear. Preliminary data indicate that HPV cancers downregulated microRNA (miR)-
203, a miRNA that enforces cell cycle arrest and differentiation and that is also downregulated during HPV
replication. Furthermore, HPV oncogenes induced the expression of several transcriptional regulators including
EZH2, a methyltransferase known to downregulate the expression of miRNAs. Consistent with a long-term
goal of studying pathways causing head and neck cancers (HNSCCs), the objective in this application is to
define viral replication pathways downstream of E6 and E7 that regulate the proliferation of HPV-positive
cancer cells and that accelerate oral tumor growth. The central hypothesis is that EZH2, which is upregulated
by E7, causes the downregulation of miR-203 leading to increased proliferation in partially differentiated tumor
cells. Targeting this EZH2-miR-203 pathway will inhibit primary tumor growth and sensitize tumors to radiation.
The rationale for this proposed research is to identify pathways involved in viral replication that can be targeted
alone or in combination with conventional therapies to more precisely treat HPV-positive cancers. This
proposal will develop innovative dual inducible genetically engineered mouse models that sequentially express
miR-203 in progressively growing HPV-positive primary oral tumors. In addition, this proposal will use small
animal image-guided radiotherapy that models the conventional therapy for HNSCCs. Preclinical observations
will be validated using a unique annotated set of human HNSCCs. This proposal is significant because it
defines the role of viral replication pathways involving EZH2 and miR-203 that may be targeted to inhibit and to
radiosensitize progressively growing oral tumors. This proposal will test the central hypothesis by pursuing
three specific aims: (1) determine the HPV oncogenes and downstream transcriptional regulators that inhibit
miR-203 expression; (2) identify cellular mechanisms by which restoring miR-203 expression inhibits
progressive oral tumor growth and increases sensitivity to DNA damage; and (3) identify cellular mechanisms
by which inhibiting EZH2 alters progressive oral tumor growth and response to DNA damage. Aim 1 will use
targeted siRNA screens and RNA sequencing to identify regulators of miR-203. Aim 2 will restore miR-203
expression in progressively growing oral tumors in order to determine the extent to which a single miRNA is
sufficient to inhibit tumor cell proliferation and to cause radiosensitivity. Aim 3 will delete EZH2 in primary HPV-
tumors in order to determine the necessity of this methyltransferase on miR-203 expression and tumor cell
proliferation. Ultimately, these results will facilitate new therapeutic strategies targeting viral replication
pathways in order to treat HPV-positive HNSCCs and, possibly, in HPV-negative HNSCCs and other HPV-
associated cancers, in general.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to identify downstream viral replication pathways pirated by Human Papillomavirus cancers that promote cell proliferation and tumor growth. The proposed research is relevant to the NIH's mission because it uses innovative models that better reflect the clinical scenario to establish the therapeutic feasibility of targeting an EZH2-miR-203 pathway in head and neck cancers, and cancers in general. The proposed research is relevant to public health because it would lead to prognostic markers and new therapeutic strategies targeting cancer cell proliferation.